Organotypic Slice Culture Model of CHIP Mediated Neuroprotection

ABSTRACT – PARENT GRANT
Protein quality control is vital for cellular function, encompassing pathways that help proteins fold and maintain
structural conformations, as well as cellular systems that ultimately degrade proteins. Several degenerative
diseases, including those that are accompanied by abnormal aging, are associated with altered protein quality
control, highlighting the importance of protein fidelity in both health and disease. CHIP (carboxyl terminus of
heat shock 70-interacting protein) is a multi-functional enzyme with distinct activities that contribute both to
protein folding and protein degradation. Our lab recently identified the first human disease associated with
CHIP mutations, with phenotypes that include accelerated aging, cerebellar ataxia and degeneration, cognitive
dysfunction, and hypogonadism. Two known CHIP substrates, receptor-interacting protein kinase 3 (RIPK3)
and AMP-activated kinase (AMPK), are regulated by either the degradative or re-folding activities of CHIP,
respectively. These kinases regulate important cellular processes, necroptosis (an inflammatory form of
programmed cell death) and cellular metabolism, both of which are central to the ability of cells to react to the
stress that occurs with aging or in pathophysiological conditions. In this proposal, we seek to define the role
of protein quality control in aging by determining how the various activities of CHIP regulate these
recently identified substrates, and the mechanism that drives the sensitivity to cell stress when CHIP
function is compromised. Our approach includes novel pre-clinical models of accelerated aging, cutting-edge
cell models, and determining the molecular movements of CHIP when engaged with its substrate. We then ask
how disease-causing mutations in CHIP mechanistically drive the molecular and cellular phenotypes
associated with CHIP dysfunction. Finally, we will use our preclinical models to determine how aging and
disease pathologies are altered when necroptosis is inhibited pharmacologically, or when CHIP function is
restored genetically. The ultimate goal of these studies is to identify druggable targets of CHIP-regulated
signaling pathways that impact age-dependent progression of degenerative conditions.

Public health relevance
PROJECT NARRATIVE – PARENT GRANT Our overall goal is to determine the mechanisms and dysfunction caused by disease-causing CHIP mutations at the atomic, cellular, and whole-body level. We will use novel cell systems in combination with our preclinical models to test novel therapies to counteract the loss of CHIP function. In doing so, we will establish a new framework to better understand this aging and CHIP biology that, in turn, will allow us to develop precision medicine approaches to alleviate degeneration caused by the loss of CHIP function.